Postdoctoral Training in Arteriosclerosis Research

This application requests continued funding, at a level of eight training positions, for a postdoctoral
training program in arteriosclerosis that began in 1978 and was last renewed on July 1, 2014. The goal of
this program is to train basic and clinical investigators with broadly based knowledge in the major fields
related to arteriosclerosis research. Atherosclerotic cardiovascular disease has a major impact on the
health of the American population, making this training program very relevant. This training program
functions within a broad framework of research dealing with various aspects of atherosclerotic
cardiovascular disease: a strength of the program is the many collaborative interactions that exist between
faculty, and collaborative research programs for trainees has always been stressed. A group of senior
scientists will act as mentors both to postdoctoral trainees working in their laboratories as well as to
other trainees in the laboratories of more junior faculty members. The program also includes training in
clinical/translational aspects of cardiovascular research. Many of the senior faculty have worked together
at Columbia for more than 25 years. They interact through research efforts, joint weekly research
conferences, and educational programs. Dr. Henry Ginsberg, PI and Director of the training program,
has been actively engaged as a mentor of young basic and clinical scientists for many years. Drf.
Ginsberg and the Associate Directors, Drs. Blaner and D'Armiento will lead an Executive
Committee that oversees research, admissions, career development and administration. Regardless of
the research focus, all trainees will enroll in didactic programs to strengthen their knowledge in
biostatistics and clinical trials and to obtain some background in basic laboratory investigation.
Mentoring is also a focus of the program. New faculty were added to bring new strengths to the
program in vascular biology and translational research. The program will continue to recruit a mix of
Ph.D. and M.D. trainees and trainees will work with a mix of M.D. and Ph.D. faculty. A program to
enhance recruitment of scientists from underrepresented ethnic groups is in place and has been
successful.

Public health relevance
This is a long-standing program to train scientists and physician/scientists in arteriosclerosis research. M.D.s and Ph.D.s trainees participate in an integrated clinical and laboratory research training program with a focus on lipoprotein metabolism, atherosclerosis in animal models, angiogenesis, and risk factor modification.